Statistical Methods In Epidemiology--general

This project develops new statistical methods for epidemiology with broad applications and also methods as needed for ongoing projects in epidemiology, particularly those related to reproductive studies. The work this year involved five main projects. (1) In work with a biostatistics graduate student at UNC (Alexandria) we are developing methods to identify the risk-relevant components in a large mixture; (2) We are considering interpretive problems related to mediation analysis when the exposure under study interacts with one of its mediators; (3) We are developing methods to analyze time to pregnancy studies in a way that is both powerful and avoids the biases that arise due to violations of the usual constancy assumptions; (4) Combined effects of sets of genetic variants and exposures; (5) We are comparing the usual methods for multi-outcome survival data with a case-only approach when the analytic goal is to compare effects of a given exposure on the distinct outcomes, e.g. different molecular subtypes of breast cancer.